PRODUCTION, ANALYSIS AND DISTRIBUTION OF CANNABIS, MARIJUANA CIGARETTES AND RELA

cultivate, harvest, store, check purity and distribute cannabis. manufacture, check strength and stability, and distribute cannabis (marijuana) cigarettes extract and isolate pure delta-9-THC and other cannabinoids from cannabis for research purposes